Periconception Vitamin D Homeostasis and Reproductive Outcomes

PROJECT SUMMARY
Pregnancy complications such as early pregnancy loss, preeclampsia, preterm birth, and fetal growth
restriction or low birthweight are common, distressing, and costly to individuals and society. While their
etiologies are multifactorial, aberrations in implantation and placentation are a common pathway. Vitamin D
has been proposed as a possible low-cost, widely accessible intervention to improve these outcomes, but
randomized controlled trials have found no benefit to supplementation among vitamin D deficient patients. The
study proposed in this application will address many of the limitations that have previously made definitive
conclusions elusive. First, as fertility care provides access to patients very early in pregnancy, we will be able
to measure periconception vitamin D in contrast to many studies which measure vitamin D in the second or
third trimesters – long after implantation and placentation are complete and too late to intervene for meaningful
benefits. Second, we will measure more than the storage form of vitamin D (25-hydroxyvitamin D, or 25(OH)D,
which is most commonly used in prior studies), as emerging evidence from other fields indicates that more
nuanced assessments such as the vitamin D metabolite ratio (VMR) and D binding protein (DBP) isoforms are
more associated with clinical outcomes. Third, we will utilize different in vitro fertilization protocols as an
experimental model for dynamic hormonal environments in which vitamin D metabolites and DBP are expected
to vary, allowing for broader investigation of alterations in vitamin D homeostasis. Our central hypothesis is that
due to its role in implantation and placentation, periconception VMR modulates the likelihood of establishing
and sustaining pregnancy as well as developing placentally-mediated obstetric complications, with varying
effects depending on DBP isoform. Supported by a team of mentors/collaborators and an advisory committee
with diverse expertise as well as the well-established research infrastructure at Penn, I will conduct a
prospective cohort study of patients seeking fertility care at our institution in order to test this hypothesis.
Aim 1 will assess the effect of different periconception hormonal environments (unassisted conceptions,
natural frozen embryo transfers, and programmed frozen embryo transfers) on VMR, with stratified analysis by
DBP isoform. Aim 2 will assess the association between VMR and live birth, early pregnancy loss, and
obstetric complications including hypertensive disorders of pregnancy, preterm birth, and low birthweight
among patients undergoing frozen embryo transfer, again with stratified analysis by DBP isoform.
In addition to answering critical questions on the role of vitamin D homeostasis in reproductive outcomes,
this study will provide me with valuable experience in prospective reproductive outcomes data collection. Along
with mentorship from renowned epidemiologists and reproductive endocrinologists, it will also prepare me for a
career as a reproductive epidemiologist as well as my longer term goal of conducting clinical trials to improve
reproductive outcomes in fertility and non-fertility patients alike.

Public health relevance
PROJECT NARRATIVE This research proposal aims to examine the role of periconception vitamin D homeostasis in reproductive outcomes, using gold standard assays to measure the vitamin D metabolite ratio and D binding protein and examining vitamin D status in a nuanced way not previously applied to reproductive medicine. Capitalizing on access to the periconception patient through fertility care, this study will assess the critically important outcomes of live birth, early pregnancy loss, and placentally-mediated complications including hypertensive disorders of pregnancy, preterm birth, and low birthweight. If a low cost, widely accessible intervention such as vitamin D supplementation is proven effective, this will have significant implications for reproductive outcomes; this is in alignment with my long-term goal of leading clinical trials on interventions to optimize modifiable factors affecting reproductive outcomes among patients trying to conceive.